Impact of Meal Timing on Glycemic Profiles in Adolescents with Type 2 Diabetes

CANDIDATE: Alaina Vidmar is a pediatric clinical scientist specializing in treatment of adolescents with obesity
and type 2 diabetes (T2D). The proposed study will focus on investigating if time-limited eating (TLE: 8-hour
eating/16-hour fasting) in adolescents with T2D reduces glycemic excursions, delays β-cell dysfunction, and
reduces body fat mass compared to prolonged eating period (12+hours). This K23 Award will provide her with
advanced training in clinical trial design and advanced statistical methods, pediatric nutrition and body
composition measurement, and glucose monitoring technology, all of which are required for her to compete for
independent R01 funding. RESEARCH CONTEXT: Preliminary evidence, mostly in adults, has shown that TLE
reduces body weight and fat mass, improves insulin sensitivity, reduces hepatic fat accumulation, and is safe
with minimal risk when compared to prolonged eating windows and has no negative effect on daily function or
lifestyle behaviors. 1–12 Because of its simplicity, TLE may represent a more feasible approach for adolescents
than other caloric restriction regimens. Our preliminary data support TLE feasibility, acceptability, and safety in
adolescents with obesity, with and without diabetes.13–15 However, no trial to date has studied the effects of TLE
on glycemic control and body composition in adolescents with T2D. We hypothesize that TLE will reduce
glycemic excursions, improve β-cell function, and reduce body fat mass in adolescents with T2D when compared
to prolonged eating periods. One-hundred adolescents with T2D (aged 14-21 years), with a hemoglobin A1c
(HbA1c) < 9%, and on Metformin monotherapy, will be recruited. All participants will be randomized to one of
two meal-timing schedules to be followed for 12 weeks: (1) Control: >12-hour eating or (2) TLE. We will examine
the effects of TLE versus control in 3 specific aims: (1) Effects on glucose control as measured by percent time
in range (captured from continuous glucose monitoring data), Hemoglobin A1c, and β-cell function (mean change
in insulinogenic index after a mixed meal tolerance test); (2) Effects on body composition and liver fat (DEXA
and magnetic resonance imaging); and (3) Effects on sleep, physical activity, and dietary intake. CAREER
DEVELOPMENT: Dr. Vidmar has access to a rich academic research environment, one of the largest pediatric
T2D populations in the country, the support of her institution, and a stellar mentoring committee consisting of (1)
Dr. Goran, a pediatric nutritional scientist, (2) Dr. Raymond, a physician-scientist with expertise in diabetes
technology, (3) Dr. Ramon Durazo-Arvizu, a statistician, (4) Dr. Espinoza, an expert in clinical bioinformatics,
and (5) Dr. Salvy, a behavioral and clinical psychologist with expertise in TLE implementation. The two co-
primary mentors, Drs. Goran and Raymond will be responsible for guiding Dr. Vidmar in achieving the milestones
towards transition to independence. In summary, this proposal meets a critical need for finding an effective
dietary intervention for treatment of adolescents with T2D and provides Dr. Vidmar with a robust training platform,
and structured mentoring path towards an R01-level competitive application.

Public health relevance
PROJECT NARRATIVE: Time-based interventions, such as time-limited eating, have been shown to be a promising dietary strategy for weight loss, glucose and lipid metabolism improvements, and overall well-being in adults with type 2 diabetes, however no study has investigated time-limited eating in adolescents with type 2 diabetes. Because of its simplicity, time-limited eating may represent a more flexible, non-stigmatizing, and low-cost approach for adolescents than other caloric restriction regimens. This project aims to determine if time-limited eating in adolescents with type 2 diabetes minimizes glycemic excursions, delays β-cell deterioration, and reduces body fat mass compared to a prolonged eating period.